Clinical Center for NICHD/Neonatal Research Network

PROJECT SUMMARY
The Eunice Kennedy Shriver NICHD cooperative multicenter Neonatal Research Network (NRN) is committed
to providing a strong scientific evidence base for the care of sick and preterm newborns to promote healthy
outcomes. Since 2011, the University of Pennsylvania Perelman School of Medicine (Penn) and Children’s
Hospital of Philadelphia (CHOP) Clinical Center has been making significant contributions to all aspects of
NRN research. Our Clinical Center includes three large level three neonatal intensive care units in academic
perinatal centers, one large level four unit in a children’s hospital, and three follow-up clinics, all of which are
unified under the leadership of the Penn/CHOP Division of Neonatology. We are a leading NRN Clinical Center
for recruitment, retention, and study follow-up. We rank #3 among the 15 current Clinical Centers for number of
infants recruited into the five currently ongoing randomized trials. Penn/CHOP 2-year follow-up rates are
consistently higher than NRN average follow-up rates. Since we joined the NRN, we have conducted follow-up
visits at 18-26 months corrected age in 98.5% (385 of 391) of Penn/CHOP study participants enrolled in 9
clinical trials. Our investigators and coordinators provide important leadership within the NRN, serving on
multiple subcommittees and facilitating startup of new centers through the NRN Open Network mechanism.
Our Principal Investigator leads two large school-age follow-up studies of NRN trials and Penn/CHOP
investigators have published 27 NRN manuscripts as first or senior author since our last competitive renewal.
We also provide unique contributions through our team’s expertise in innovative epidemiological techniques
and health disparities. We are fully prepared to continue our robust participation in the NRN by contributing our
team’s special strengths in clinical research methodology, collaborating as collegial and productive partners in
ongoing studies, and introducing innovative new protocols to advance the scientific mission of the NICHD NRN
in the next award cycle.

Public health relevance
PROJECT NARRATIVE The Eunice Kennedy Shriver NICHD cooperative multicenter Neonatal Research Network (NRN) is committed to providing a strong scientific evidence base for the care of sick and preterm newborns to promote healthy outcomes. The University of Pennsylvania Perelman School of Medicine (Penn) and Children’s Hospital of Philadelphia (CHOP) Clinical Center has been making significant contributions to all aspects of NRN research since 2011 and is fully prepared to continue our robust NRN participation in the next award cycle.